Biomarkers of dasatinib response and resistance in T-cell acute lymphoblastic leukemia

Abstract
Acute lymphoblastic leukemia (ALL) is the most common cancer in children, with T-cell ALL accounting for 15% of
cases. T-ALL in children is associated with aggressive clinical features and inferior treatment response to
combination chemotherapy, compared to B-cell ALL. Further intensification of cytotoxic drug-based therapy is
ineffective for relapsed T-ALL and novel agents are much needed for these patients. We recently discovered
that a significant proportion of pediatric T-ALL exhibits exceptional response to tyrosine kinase inhibitor dasatinib,
in an ABL-independent fashion. Our preliminary genomic analyses pointed to the activation of the preTCR-LCK
signaling pathway as a potential driver of this drug response phenotype. We have developed an innovative
systems biology approach that integrates transcriptional profile with functional ex vivo drug testing in order to
develop a clinically translatable biomarker for sensitivity and resistance to dasatinib in T-ALL. We hypothesize
that our systems biology approach can comprehensively identify molecular determinants of dasatinib response
in T-ALL, and that dasatinib-sensitive T-ALLs have distinct clinical and genomic features.
In this project, we propose to 1) develop a systems biology-based biomarker model of dasatinib sensitivity in T-
ALL; 2) systematically characterize genomics and clinical features associated with dasatinib sensitivity in T-ALL,
and 3) explore mechanism of dasatinib resistance in T-ALL and develop biomarker-driven combination therapy
to overcome drug resistance.
Successful completion of these studies is likely to substantially shift the paradigm of how pediatric T-ALL is
treated and significantly impact the next generation of clinical trials and improve cure rates for children with this
devastating illness.

Public health relevance
Project Narrative Many children with T-cell acute lymphoblastic leukemia (ALL) are not cured and chemotherapy is already very strong with many side effects. Curing more children requires new medicines and not more of the same, and we recently discovered that a drug called dasatinib is very good at fighting cancer cells from children with T-ALL with few toxicities. In this project, we propose to figure out which children with T-ALL are likely to respond to dasatinib and this information will help us develop individualized therapy for this cancer.